Navigating the Waters of the US Healthcare System: Improving the Biopsychosocial Health of Fishing Industry Workers

PROJECT SUMMARY/ABSTRACT
Work-related injuries have been shown to predict physical illness, mental wellbeing, and substance misuse,
and these latter factors are known contributors to high rates of occupational injury. This bidirectional
relationship is particularly strong for people exposed to social determinants of health (SDoH) like dangerous
work conditions and limited sick leave benefits, as well as those who lack ready access to preventive
healthcare. One occupation suspectable to potentially high rates of injury and substance misuse is commercial
fishing. Primary and secondary prevention interventions, such as increasing the use of healthcare navigators
and emphasizing the SDoH have been shown to effectively improve biopsychosocial health disparities among
historically marginalized populations. Healthcare navigators are connected to the community (e.g., wife or child
of fishermen) and establish and maintain relationships with the participants who are receiving healthcare
services or need assistance finding social services. A more nuanced paradigm can build on previous SDoH
research that engages healthcare navigators to facilitate biopsychosocial well-being for fishermen, including
studying the relationship between workplace hazards and substance misuse; screening for physical,
psychological, and behavioral health problems; and referring to relevant healthcare professionals or
paraprofessionals. Specifically, we will 1) examine the link between and mechanisms underlying occupational
injuries and substance misuse to inform clinical needs by conducting semi-structured interviews and participant
observation 2) implement and study the feasibility of healthcare navigators by identifying and addressing
biopsychosocial factors that lead to increased injury and substance misuse, and 3) evaluate whether and how
commercial fishermen use and access the healthcare navigators to reduce injury and substance use. In
addition to extending collaborations among fishing partnership agencies on addressing injury and substance
misuse, this is among the first projects to implement and evaluate the feasibility of using healthcare navigators
with Gulf Coast shrimp fishermen to improve biopsychosocial health.

Public health relevance
PROJECT NARRATIVE There is a critical need for occupational health to understand the bidirectional relationship between injury and substance misuse, and to address these interlinked issues by improving biopsychosocial factors among low SES workers.